Oligo(lactic acid)n-Prodrug Nanomedicines for Combination Therapy

Project Summary/Abstract
Taxol is commonly used to treat TNBC and increasingly in combination with oral signal transduction inhibitors
(STIs), such as mTOR inhibitor (Afinitor) and MEK inhibitor (Koselugo), aiming for targeted therapies for this
genetically heterogeneous disease. However, while these drug combinations are active in TNBC, they are
associated with adverse effects, limiting clinical effectiveness. Our objective is to investigate oligo(lactic acid)
(o(LA)n-) prodrugs, part drug and part biomaterial, and poly(ethylene glycol)-block-poly(d,l-lactic acid) (PEG-b-
PLA) nanotechnology for the treatment of TNBC, focusing on concurrent delivery of drug combinations, including
delivery at synergistic drug ratios, termed ratiometric drug dosing. We will achieve this goal by developing a
scale-up approach for the controlled assembly of o(LA)n-prodrugs and PEG-b-PLA micelles that produces novel
nano-formulations for injection, characterized by high loading for a wide repertoire of chemotherapy and STIs,
fixed o(LA)n-prodrug ratios and slower release in comparison to drugs themselves. Next, ratiometric dosing of
o(LA)n-prodrug-loaded PEG-b-PLA micelles based on PTX, rapamycin (RAP) and selumetinib (SEL) will be
characterized in immunocompetent mouse models of TNBC, hypothesizing lower toxicity and higher antitumor
activity than Taxol, oral EVE and oral SEL. Mechanistically, we hypothesize that o(LA)n-prodrugs will prolong,
elevate and overlap tumor exposure for synergistic drug ratios in comparison to Taxol, oral EVE and oral SEL.
Further, o(LA)n-prodrug combinations may be potent immuno-modulators, which may be exploited for TNBC.
Given that PEG-b-PLA micelles satisfy strict requirements in safety, solubility and scale-up for injection and PEG-
b-PLA is readily available GMP-grade at varied molecular weights for adjustment of micelle stability in vivo,
o(LA)n-prodrugs have strong potential to improve the effectiveness of drug combinations based on PTX and
STIs, aimed at advancing TNBC therapies.

Public health relevance
Project Narrative This proposed research is relevant to public health because triple-negative breast cancer (TNBC) is the most lethal breast cancer with limited treatment options. The goal is to develop nano-formulations based on oligo(lactic acid)n-prodrugs, based on paclitaxel, rapamycin (mTOR) and selumetinib (MEK), focusing on scale-up of GMP- grade material, physicochemical properties, toxicity, pharmacokinetics and biodistribution and evaluation in murine tumor models of TNBC. Nano-formulations based on oligo(lactic acid)n-prodrugs, safely injected as 2- or 3-drug combinations, will prolong, elevate and overlap tumor exposure and potentially exceed antitumor efficacy of standard-of-care (Taxol), oral everolimus and oral selumetinib, which have been tested in clinical trials.